Defining a Crisis: Engagement with Crisis Call Centers and Mobile Crisis Teams

7. Project Summary/Abstract
In July 2022, 988 will become the nationwide 3-digit suicide prevention phoneline to access the National
Suicide Prevention Lifeline (NSPL). The nationally recognized Zero Suicide (ZS) model has endorsed crisis call
centers (CC) and mobile crisis (MC) as key strategies to prevent suicide. Crisis services are also envisioned as
a means of increasing access to care for populations that have historically faced barriers to receiving care,
including Black/African Americans, people experiencing homelessness, and people living in rural areas. When
988 goes live, the NSPL is expected to expand beyond its current role as a suicide hotline and transform into
an entry point for a range of mental health crises as well as a means of dispatching MC teams. However, little
is known about what types of calls may come to 988 or what factors will need to be considered to develop best
practices in crisis triage decision-making. There is an urgent need to expand the evidence base to inform best
practices in CC and MC settings, which are routinely caring for people at high risk of suicide. To fill this gap,
this study will leverage a large, comprehensive clinical dataset from Georgia’s statewide crisis system—which
is widely regarded as a national leader in crisis services—to characterize CC and MC practices and provide
guidance to crisis programs as the US begins to roll out 988. In Aim 1, we will conduct a latent class analysis to
quantitatively describe common clinical phenotypes of adults accessing crisis services through a statewide CC
between 2016 and 2018 (n=235,762), which can inform what types of crises need to be addressed by 988 call
centers. In Aim 2, we will examine sociodemographic, clinical and regional factors that may be associated with
referral decisions by Georgia’s CC (n=235,762) and MC (n=34,371), with a particular focus on disparities
among groups that historically have poorer access to care. Finally, in Aim 3, we will leverage Georgia’s use of
a clinical decision-support tool called the Level of Care Utilization System (LOCUS) to examine cases in which
the actual CC referral differs from the most appropriate level of care recommended by the LOCUS, which
allows for detection of cases where referral options may be limited. These studies will fill critical gaps in the
evidence base to advance our understanding of best practices for suicide prevention in crisis services and will
help prepare the US for major crisis system transformations such as 988. The figures presented below are the
actual number of mobile crisis visits between 1/1/2016 and 12/31/2018 in the GCAL database.

Public health relevance
8. Project Narrative Crisis call centers and mobile crisis teams play a key role in suicide prevention. Crisis services are soon to be transformed thanks to nationwide implementation of 988, the new 3-digit number for the National Suicide Prevention Lifeline set to go live in July 2022. By examining a comprehensive clinical dataset from a national leader in crisis services, this study will provide critical guidance to crisis programs as the US begins to roll out 988 inform best practices in call center and mobile crisis settings.